The UCLA Pulmonary and Critical Care Medicine Scientist Training Program (PCCM-STP)

PROJECT SUMMARY/ABSTRACT
This is the renewal application for a multidisciplinary training program in Pulmonary and Critical Care Medicine
(PCCM) at the David Geffen School of Medicine (DGSOM) at UCLA. The program will continue to provide training
in basic science and clinical research relevant to the study of PCCM-related diseases. The program proposes to
continue to support a total of six postdoctoral trainees (MDs, PhDs and MD/PhDs) for a two year experience in
a highly structured environment under the close supervision of faculty mentors. The trainees will take advantage
of these experienced faculty mentors whose research encompasses the following themes: 1)
Infection/Inflammation/Transplantation/Fibroproliferation, 2) Lung Carcinogenesis, 3) Health Services Research
and Prevention, 4) Biomedical Informatics, Systems Biology and Data Science and 5) Vascular Biology and Rare
Diseases. The program will continue to utilize faculty mentors from several Departments in the DGSOM, Fielding
School of Public Health and Henry Samueli School of Engineering and Applied Science at UCLA. The faculty
mentors have extensive research experience in diverse, yet overlapping areas of molecular and cellular biology,
immunology, psychiatry and biobehavioral sciences, internal medicine and health sciences, health policy and
management, biomedical, biostatistics and bioinformatics, cancer signaling and metabolism, computer science,
vascular biology and clinical study design. The vast majority of the faculty mentors have previously trained
postdoctoral trainees who have subsequently gone on to independent and productive careers in academia or
industry. The environment at UCLA together with the faculty mentors will continue to offer an outstanding
experience for trainees in research disciplines relevant to PCCM-related diseases. The program will continue to
provide a structured curriculum that contains appropriate supervision, coursework, exposure to relevant lecture
series and an intensive basic science or clinical research experience, while sustaining resilience for the sciences.
The training program has been highly successful in developing new investigators with the majority of trainees
continuing in research careers in academia or industry.

Public health relevance
PROJECT NARRATIVE Diseases related to pulmonary and critical care medicine (PCCM) remain among the leading causes of morbidity and mortality. The UCLA Pulmonary and Critical Care Medicine Scientist Training Program (PCCM-STP) is dedicated to mentored, interdisciplinary team-based training of a new generation of academic and industry leaders in basic, clinical translational and health services research. By deploying facilities and resources of renowned multidisciplinary mentor faculty, we will fulfill the program mission of training a cadre of investigators who will discover novel underlying basic principles of PCCM-related diseases and translate these discoveries to improve health.